Radiation Oncology at the Interface of Pediatric Cancer Biology and Data Science

Project Summary
Basic scientists and clinical investigators from Dana-Farber/Harvard Cancer Center (DF/HCC) join forces with
their counterparts at University of California, San Francisco’s (UCSF) Helen Diller Family Comprehensive
Cancer Center to propose a Harvard/UCSF ROBIN Center. Our Objective is to improve potency and
selectivity of two key radiation modalities--external beam radiation and radiopharmaceuticals. A distinctive
feature of our ROBIN Center is its selection of two clinically aggressive pediatric tumors--diffuse midline glioma
(DMG) and high-risk neuroblastoma (NBL) – as scientific vehicles for the study plan. The genetic drivers of
these two pediatric cancers are found also in more common adult solid tumors. Moreover, the low mutational
burden of these pediatric cancers provides a clean genetic background for the “low N/high content” Molecular
Characterization Trials (MCTs) specified by the ROBIN RFA. The malignant cells within DMG and NBL are
heterogenous with respect to developmental stage. The central hypothesis of our study plan is that this
developmental heterogeneity is echoed at the level of radiation-response mechanisms and enables radiation
resistance. Our study plan features two research projects configured to test predictions of this hypothesis.
Project 1 draws upon paired samples of pre-and post-radiotherapy tumor tissue from children treated
prospectively with a uniform radiotherapy regimen to test the prediction that radiation selects for radioresistant
intra-tumoral variants. Project 2 tests the prediction that 131I-MIBG therapy of aggressive neuroblastoma
selects for intra-tumoral subtypes with unfavorable responses to treatment. Our ROBIN MCT provides
resources needed to complete the objectives and specific aims of the two Projects. Multimodal analysis and
mathematical modeling of data from the Projects and the MCT will be performed in a Clinical Artificial
Intelligence and Imaging Core and a Molecular Data Science and Advanced Dosimetry Core. A Cross-
Training Core and an Administrative Core will support scientific activities and serve also as the Center’s
“outward face” to the broader scientific community and lay public.
The Center will serve as a “value-added” component of the NCI’s extramural support mission by
leveraging (i) P30 core facilities of DF/HCC and UCSF, (ii) a U54-funded DFCI Physical Sciences Oncology
Center, and (iii) the NCI's Experimental Therapeutics Clinical Trials Network and National Clinical Trials
Networks. Conversely, an NCI ROBIN award to the Harvard/UCSF Center would be “value-added” to the field
of radiation oncology by catalyzing productive interactions between radiation biology, artificial intelligence, and
data science – disciplines that are well-established in Boston and San Francisco but have never been applied
coordinately to the problem of radioresistance. Center co-leads, Professors Daphne Haas-Kogan M.D. and
Franziska Michor, Ph.D. have much experience in management of multi-investigator, multi-institutional
research programs together with complementary skillsets in radiation oncology and advanced data science.

Public health relevance
Radiation therapy is efficacious for many cancers but only partially effective, or totally ineffective for many others. The National Cancer Institute has issued a request for multi-institutional teams to improve the potency of radiation and expand its repertoire of responsive tumors through formation of a Radiation Oncology Biology-Integration Network (“ROBIN”). In response, scientists and clinicians from the Dana-Farber/Harvard Cancer Center in Boston have joined forces with their counterparts at the University of California, San Francisco to propose a Harvard/UCSF Robin Center.